The Florida Pediatric NCORP renewal application for grant# UG1CA189973 to continue participation in the NCI Community Oncology Research Program.

Project Summary
The Florida Pediatric NCORP will be a consortium of five Florida hospitals. The NCORP will
geographically cover a large portion of Florida and will provide pediatric oncology care to the
largest population centers in Florida, the third largest state in the country. The hospitals are
located in Ft. Myers, Hollywood, Orlando, and two sites inTampa, as well as the Central Office.
Over a 34 year period the Florida Pediatric CCOP and now Florida Pediatric NCORP is among
the single largest contributor of patients to COG treatment, cancer control, and over the last two
years, cancer care delivery studies. The CCOP and now the NCORP has consistently had
outstanding compliance scores and contributes to the administration and science of COG
through its members who chair or co-chair research base protocols. The goal of the Florida
Pediatric NCORP will be a continuing effort to make available the latest advances in cancer
care to patients in Florida through participation in clinical trials and to register the majority of
their eligible patients on COG protocols, thereby providing quality care in patients’ home
communities. The Florida Pediatric NCORP will provide a unique opportunity to study a
geographically-defined population to investigate risk factors, patterns of care, and population-
based interventions. The Florida Pediatric NCORP will also maintain a Patient Log which affords
the opportunity to ensure the majority of eligible patients are registered on appropriate COG
protocols. Over the last grant cycle, the five Florida Pediatric NCORP participating sites have
averaged 270 patient registration on COG treament, cancer control, and cancer care delivery
protocols, as well as 321 biospeciem. The Florida Pediatric NCORP anticipates increased
patient registrations as more COG treatment, cancer control, and cancer care delivery protocols
become available. COG quality-control procedures will apply uniformly to the Florida Pediatric
NCORP, ensuring compliance with protocols and external review of pathology, radiotherapy,
surgery, and chemotherapy.

Public health relevance
Project Narrative The Florida Pediatric NCORP will maintain its single focus to make the latest advances in cancer care available to large segments of Florida through participation in treatment, cancer control and CCDR trials through its affiliation with the Children’s Oncology Group.